Analytical Core B

The Analytical Core (B) will be located in the Biomedical Biological Sciences Building, University of Kentucky. The Analytical Core will consist of the Director and research personnel for performing services of resolution and profiling of analytes using mass spectroscopy and for quantifying analytes using luminex platforms. An important part of Core activities will include methods development to analyze specific molecules of interest, and for profiling lipids within animal and human tissue.

Public health relevance
The Analytical Core provides services and methods development to investigators of the Center to quantify, profile and resolve various analytes, with a focus on lipids.